Nebraska Occupational Safety and Health Surveillance Program

Project Summary
The purpose of the Nebraska Occupational Safety and Health Surveillance Program (NOSHP)
is to conduct state-based occupational health and safety surveillance within the State of
Nebraska. The Nebraska Department of Health and Human Services has authority for
supervision, control, and responsibility over matters relating to public health within the state.
Occupational health indicators will be compiled and reported on an annual basis (Aim 1). We
will further enhance occupational health surveillance by collecting, analyzing, and interpreting
occupational injury and illness burden and trends using existing state-based data sources.
NOSHP will conduct surveillance and investigation for adults with elevated blood lead levels
(Aim 2). We will share our findings with our partners through reports, factsheets, and
presentations to inform best practices, target interventions, and provide recommendations for
prevention (Aim 3). In addition to surveillance activities, our program will maintain existing
relationships and build new partnerships with local, state, and national stakeholders to integrate
occupational health into mainstream public health (Aim 4). We will enhance occupational health
surveillance through using health informatics strategies (Expanded Aim 5). NOSHP will collect,
analyze, and report on occupational data involving COVID-19 and other infectious diseases. We
will explore the use of syndromic surveillance data to supplement occupational safety and
health surveillance. Through our work, expect to improve surveillance systems, identify new
emerging issues and priorities, and improve the knowledge of the causes and conditions of
workplace injury and illness. Ultimately, the project’s aims and activities will help NOSHP reach
its overarching goal of reductions in workplace injury, illness, and death.

Public health relevance
Project Narrative Workers in Nebraska face risks to their health, safety, and well-being at their workplaces. State- based surveillance systems for occupational injuries and illnesses can provide critical data to assess the burden and trends of occupational morbidity and mortality in order to inform prevention efforts. The overall goal of the Nebraska Occupational Safety and Health Surveillance Program is to enhance public health surveillance in order to reduce the incidence of work-related injuries, illnesses, and exposures.